Sex differences in the role of multi-omics in HIV-associated carotid artery atherosclerosis

PROJECT SUMMARY/ABSTRACT
While significant recent changes in the clinical care of people with HIV (PWH) (e.g., universal ART initiation,
greater use of statins as prophylaxis) have reduced cardiovascular disease (CVD) risk, concurrent
developments that may increase CVD risk (e.g., shift to integrase inhibitors as first-line HIV treatment,
continued aging of the HIV population) mean that the determinants of CVD in PWH are ever-changing. We
have the opportunity to extend our existing database of -omics measures in women in relation to HIV-
associated CVD in the MACS/WIHS Combined Cohort Study (MWCCS) to men, and expand the scope with
additional assessments of the microbiome, metabolome, and sex hormones. We propose to use archived
specimens to measure gut microbiota and selected microbiome-related metabolites and immune marker
panels, including markers of immune activation, gut barrier dysfunction and microbial translocation in relation
to carotid atherosclerosis in MWCCS men, and assess both the independent and mediating roles of sex
hormones in this relationship among both women and men with HIV. Our aims support HIV/AIDS research that
falls under the following NIH high priority AIDS-designated topics: 1) immune dysfunction, persistent
inflammation, and microbiome and genetic determinants that underpin the development of high priority HIV co-
morbidities, and 2) long-term treatment or prevention strategies for HIV-relevant comorbid conditions across
the lifespan.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is the leading non-AIDS cause of death in people with HIV (PWH), with atherosclerosis being a major contributor to the excess morbidity and mortality observed in PWH that is only expected to grow as the population continues to age. Our study is one of the few with objectively measured data on subclinical atherosclerosis in the same PWH longitudinally, contributing unique data on the long-term predictors of CVD in the context of HIV. As the largest HIV-focused study (to our knowledge) of the gut microbiome in relation to CVD, this Supplement will produce high impact science to enhance our understanding of known, hypothesized, and as-yet-discovered pathways leading to HIV-associated atherosclerosis, by identifying functional intermediators (e.g., microbiota species, microbial metabolites) linking the microbiome to atherosclerosis, and examining whether these pathways differ by levels of sex hormones in men and post-menopausal women with HIV.